STEREODEFINED OLEFIN SYNTHESIS VIA TANDEM PD-CATALYSIS

DESCRIPTION: The long-term objective of this project is to improve efficiency in synthetic chemistry through the development of "one-pot" reaction sequences that combine mechanistically unrelated transformations. Such pursuits are intended to increase the scope of tandem reactions available to the organic chemist. Tandem reactions can decrease the amount of time, waste, and cost associated with the synthesis of important target molecules. Specifically, this methodology is being developed with direct application to the synthesis of stereodefined di- and trisubstituted olefins, which are common functionalities found in a number of natural products and medicinally important pharmaceuticals, and a challenge to prepare efficiently and stereoselectively. The immediate goal is to design and prepare stereodefined "olefin templates" that are suitably functionalized for elaboration to olefin-containing targets. Dihalo-, trihalo-, bimetallo-, monohalo-bimetallo-, and dihalo-monometallo-propene derivatives of defined stereochemistry can be readily prepared. Such species undergo Ni- and Pd-catalyzed ionic allylic substitution and insertion/coupling reactions with high degrees of stereospecificity, i.e. retention of configuration. Although these transformations are mechanistically different, they can be combined into a one-step operation since both utilize the same catalyst and solvent. Therefore, sequential addition of the appropriate reagents will systematically substitute each functionality of the olefin template over the course of the sequence, while maintaining the stereochemistry of the olefin template. Overall, this represents a convergent, stereodefined approach to olefin-containing targets. Preliminary results have been obtained on both disubstituted- (i.e. 2,3-dibromo-1-propene) and trisubstituted- (i.e. 1,1,3-tribromo-1-propene) olefins. Allylic substitution with soft nucleophiles followed by coupling reactions with both terminal alkynes and aryl and vinyl organometallic reagents, all catalyzed by palladium tetrakis(triphenylphosphine), have provided stereodefined olefin products of diverse structure in high efficiency when compared with the same reactions performed independently. The ultimate goal of these pursuits is to develop di- and trifunctional olefin templates that can be used by scientists in several disciplines to approach the synthesis of any stereodefined polysubstituted olefin.